Mechanism of the telomeric proliferation limit

Project Summary/Abstract
This project focuses on the biology of telomeres, the protective elements at chromosome ends whose erosion
limits the replicative lifespan of primary human cells. Telomere dysfunction has been implicated in a number of
human diseases, including inherited bone marrow failure syndromes and cancer. We aim to understand how
telomeres protect chromosome ends and how they are maintained. Insights into these issues resulted from our
studies of shelterin, the six-subunit protein complex that binds to telomeric DNA. Shelterin is anchored on
telomeres by two telomeric DNA binding proteins, TRF1 and TRF2, which promote telomere replication and
protect telomeres from the DNA damage response, respectively. This proposal focuses on these two critical
telomere factors. In AIM 1, we will critically test the leading model in the field that telomeres are protected through
the formation of the t-loop structure by TRF2. We have previously shown that TRF2 is required for t-loop
formation and our preliminary data indicates that TRF2 is sufficient to create this structure. Despite the popularity
of this model, there is no direct proof that t-loops repress the DNA damage response. We are developing
orthogonal (TRF2-independent) tools for t-loop formation and will test whether generation of t-loops is sufficient
to repress the DNA damage response in absence of TRF2. In AIM 2, we will investigate how TRF2 generates t-
loops. T-loop formation is thought to require the TRFH domain of TRF2 but how this domain acts is not clear.
Our preliminary studies of the TRFH domains of TRF2 (which forms t-loops) and TRF1 (which does not) have
identified features of the TRF2 TRFH domain with potential relevance to t-loop formation. These attributes will
be tested for their relevance to telomere protection in vivo. In AIM 3, we will study the role of the TRF2 Myb
domain in the protection of telomeres. Our preliminary data challenge the widely-held view that the TRF1/2 Myb
domains only function as DNA binding modules and suggest that they have additional functions, potentially
through protein-protein interactions. We will pursue our hypothesis, based on our preliminary data, that the Myb
domain of TRF2 mediates a critical role in telomere protection. In AIM 4, we will investigate the function of TRF1
in telomere replication. Loss of TRF1 induces fragile telomeres, replication fork stalling, and sister telomere
associations. Our preliminary data show how TRF1 uses the BLM helicase to prevent lagging-strand replication
problems, most likely caused by G4 DNA. We propose to investigate how TRF1 prevents leading-strand
replication problems, fork stalling, and sister telomere associations. We will expand on our preliminary data
indicating that the sister telomere associations represent a novel type of telomere fusion resulting from a
previously unrecognized alt-NHEJ mechanism involving stalled replication forks. This project will use innovative
approaches and our established biochemical, cell biological, and molecular genetic tools to reveal new concepts
in telomere biology with relevance to age-related human disease states.

Public health relevance
Project Narrative (2-3 sentences) Loss of telomere protection is the proximal cause of several life-threatening inherited aging disorders and plays a major role in the etiology of cancer, a disease correlated with aging. This project aims to reveal the molecular basis of telomere function with the long-term goal to gain deeper insight into how diminished telomere protection contributes to human age-related diseases.